A gender and culturally specific approach to reduce NAFLD in Mexican American men

ABSTRACT
Effective therapeutic interventions are needed to stem the alarming increases in non-alcoholic fatty liver
disease (NAFLD) in Mexican-American men, an understudied population at greater risk for the development of
hepatocellular carcinoma (HCC). Primary lifestyle risk factors for NAFLD include physical inactivity and sugar-
sweetened beverage consumption, characteristics that are highly evidenced in Mexican-American men. The
risk of NAFLD is further increased in Mexican-American men by a greater frequency (up to 55%) of the risk
allele at the PNPLA3 (patatin-like phospholipase domain-containing protein) gene. This allele confers a
substantially greater susceptibility to NAFLD and HCC. In the absence of FDA-approved pharmaceutical
agents, lifestyle modification, including weight loss initiated by improvements in dietary and physical activity
behavior, is the recommended therapy for the prevention and treatment of NAFLD. Lifestyle interventions
targeting modest weight loss (approximately 5% body weight) have been shown to result in significant
reductions in liver fat. However, evidence regarding the effects of a lifestyle intervention designed exclusively
for Mexican-American men at greater risk for NAFLD is not currently available. Dr. David Garcia has an
excellent foundation in lifestyle interventions that has positioned him well to advance toward his goal of
reducing obesity-related disease burden in Mexican-American males. The goal of this NIMHD K01 Mentored
Research Scientist Development Award is to provide Dr. Garcia with an in-depth understanding of metabolic
and pathogenic pathways and risk factors of obesity-related cancers and related diseases, with a specific focus
on NAFLD and HCC in Mexican-American men. He also will gain training in non-invasive imaging biomarkers
(e.g., transient elastography) for the evaluation and management of disease state and risk factors. Lastly, he
will advance his knowledge and skill development in research methodologies (e.g., quantitative analysis and
qualitative inquiry) that informs on the design and tailoring of a culturally-specific study to reduce the burden of
NAFLD. With the mentorship of Dr. Cynthia Thomson and Dr. Michael Fallon, co-mentors, and collaborators;
for the proposed project Dr. Garcia intends to 1) use an available dataset from the Cameron County Hispanic
Cohort (CCHC) to assess risk for NAFLD, including the influence of phenotypic factors (lifestyle behaviors) in
Mexican-American men; 2) evaluate the knowledge, attitudes, and beliefs of obesity-related cancer risk, with
an emphasis on NAFLD and HCC risk in Mexican-American men; and 3) assess the feasibility, acceptability,
and preliminary efficacy of a NAFLD-specific weight loss intervention tailored for Mexican-American men. The
training plan and research strategy in this K01 application will afford Dr. Garcia the time, resources, and
mentorship necessary to achieve his career goal which is enthusiastically endorsed by University of Arizona
leaders and an extremely appropriate and supportive research environment.

Public health relevance
PROJECT NARRATIVE Rates of non-alcoholic fatty liver disease (NAFLD), a modifiable premalignant state associated with hepatocellular carcinoma are highest in the nation for Mexican-American men, the fastest growing Hispanic sub-group. The training and proposed research will utilize a NAFLD-specific weight loss intervention to reduce the burden of this disease and improve health outcomes for this high-risk population.